District of Columbia Center for AIDS Research

Modified Project Summary/Abstract Section

The District of Columbia Center for AIDS Research (DC CFAR) was established in 2010 to galvanize HIV research in Washington, DC in response to one of the most severe urban HIV epidemics in the United States The DC CFAR has a unique citywide multi-institutional model with 260 investigator members at nine collaborating institutions: four universities - George Washington, Georgetown, Howard and American; two hospitals - Children’s National Hospital and the DC Veterans Affairs Medical Center; two community-based organizations - Whitman-Walker and Us Helping Us, People Into Living; and the DC Department of Health. The DC CFAR mission is to “Advance our multi-institutional research effort to contribute to ending the HIV epidemic and improving the health and quality of life of persons with HIV in Washington, DC and beyond in partnership with community and government.” The DC CFAR will address this mission through four Specific Aims which briefly are to: provide scientific leadership and institutional infrastructure; stimulate and support HIV research; develop the next generation of HIV investigators; and foster communication and collaboration. To address these Aims, the DC CFAR will support five Cores: the Administrative Core to provide overall leadership and management; the Developmental Core to oversee an array of pilot award and mentoring programs; and the Advanced Technology, Clinical and Population Sciences, and Social and Behavioral Sciences Cores to provide technical services, consultations and training. The DC CFAR will support two Scientific Working Groups – HIV Persistence and Cure, and Aging and Comorbidities, and one Scientific Interest Group on Women and HIV. To promote HIV research in this high priority area. The DC CFAR provides the vital infrastructure that interconnects the multisectoral HIV research response in DC, and the resources to help propel this response forward. Sustaining the commitment to the DC CFAR and its mission is essential to ending the HIV epidemic in our nation’s capital.

Public health relevance
Modified Public Health Relevance Section The DC CFAR’s mission is to advance our multi-institutional research effort to contribute to ending the HIV epidemic and improving the health and quality of life of persons with HIV in Washington, DC and beyond in partnership with community and government. The CFAR achieves this mission by providing scientific leadership and institutional infrastructure to promote and support HIV science across collaborating DC CFAR institutions; stimulating and supporting innovative, interdisciplinary, and impactful basic, clinical, and social and behavioral science research in the NIH high priority HIV scientific focus areas; driving the development and recruitment of early stage and new investigators through an array of innovative pilot award and mentoring programs; and fostering communication and collaboration with academic, community, government, clinical and CFAR network partners.